NATURAL HISTORY OF CONGENITAL CYTOMEGALOVIRUS INFECTION

The purpose of this project is to define the natural history of central nervous system sequelae among children with congenital (CMV) infection. We will examine maternal & infant clinical characteristics, virologic findings (such as viremia) & immune responses to specific CMV proteins as determinants of outcome.